STUDIES ON MODELS OF THE AUDITORY PERIPHERY

The overall goal of the project is to provide an accurate and comprehensive computer model of the entire auditory periphery that will simulate the cochlear-partition macromechanical and micromechanical vibrations, the hair-cell voltages, and the auditory-nerve-fiber discharge patterns produced by any acoustic signal presented anywhere in space. This model will be built around a currently working model of cochlear- partition vibrations (hydrodynamics) that was developed during the last grant period. The project has 3 specific aims. The first aim is to improve the accuracy of the current hydrodynamic model. Of particular importance is the low-frequency section of the model, which appears to require fundamentally different simulation than does the high-frequency section. The second aim is to expand the model by including representations of other parts in the peripheral transduction process: the middle and external ears, the hair-cell transduction processes, the hair- cell/afferent-nerve-fiber synapses, and the efferent systems. The third aim is to adapt the model, now representing the cat's periphery, to represent that of the human and the mustached bat.